Bayesian Network Biomarker Selection in Metabolomics Data

Metabolomics is one of the major areas of high-throughput biology. Metabolomic profiling by liquid chromatography-mass spectrometry (LC/MS) measures thousands of metabolites at the same time. The LC/MS metabolomic profiling data poses unique challenges due to several characteristics including the intrinsic uncertainty in matching features to known metabolites, the mixing of true zeroes and missing values, and distinct data distribution and dependency patterns that hamper integrative analysis with other types of high- dimensional data. In this study, we plan to tackle the problems by developing Bayesian hierarchical models for network marker selection that incorporates matching uncertainties, a regression framework for integrative analysis of multipartite omics networks, and a novel modeling strategy to address the unique challenge of missing values in the metabolic network. We will apply newly developed methods to large-scale, high-impact metabolomics and transcriptomics data to derive new biological insights, and provide easy-to-use software for the community.

Public health relevance
Bayesian network biomarker selection in metabolomics data Narrative: Metabolomic profiling data poses unique challenges that have not been addressed so far. In this study, we plan to tackle the problems by developing new Bayesian hierarchical models to select network biomarkers, a new framework to integrate metabolomics data with other types of high-dimensional data, and a novel strategy to address the unique challenge of missing values in the metabolic networks. 1